SBIR TOPIC 104, FAST-TRACK, TAPERED GUIDEWIRES FOR TRANSCATHETER ELECTROSURGERY

The contractor will develop specific guidewire devices to ease and simplify transcaval access to the aorta, to make the procedure available to a wider range of patients and operators.